An automated device for quantifying DNA damage

PROJECT SUMMARY
Genomic instability, induced by DNA damage, plays a critical role in the pathogenesis of many major human
diseases, such as neurodegeneration, cancer, and cardiovascular disease, together with aging. A critical need
exists for automated assays that can assess DNA damage and thereby bring the measurement of such damage
into greater routine use, which will help advance our understanding of disease and its environmental causes.
The comet assay, a widely used and versatile means of measuring many types of DNA damage, has been
integrated into various regulatory guidelines for screening chemicals and pharmaceuticals e.g., the Organization
for Economic Cooperation and Development guidelines, the European Commission’s Registration, Evaluation
and Authorization of Chemicals Program, and ICH S2(R1) guidance 16. Moreover, its use has far-reaching
recommendations e.g., the FDA, the National Toxicology Program, the European Food Safety Authority; the
International Conference on Harmonization of Technical Requirements for Human Use; and the European
Medicines Agency.
However, the comet assay is time-consuming and labor intensive (multiple steps and multiple sample
slides processed individually by hand), downsides which can also introduce errors and variation and be
problematic for users. These limitations can be addressed by assay automation, a workflow solution that is
currently absent in the market. Our Phase I project resulted in a novel, prototype Automated High-Throughput
Comet Assay Device (AHTP-CAD) that successfully automated the comet assay without the need for operator
involvement. A Technology Niche Analysis subsequently confirmed the demand, and identified potential markets.
In this Phase II application, we will refine, optimize, and test the AHTP-CAD for benchtop use and
widespread adoption. We will develop manufacturing/assembly processes and procedures for scaling up to high
volume production. We will also benchmark and assess the operation of the AHTP-CAD to support users in
performing their assays in compliance with Good Laboratory Practice. At the project completion, we expect a
commercialization-ready device, which will uniquely address the unmet need of providing users with a
standalone, automated analysis of DNA damage. The device will be sufficiently developed for demonstration to
potential commercial partners.
The availability of such a self-contained benchtop device will accelerate biomedical discovery and
address the NIH mission of seeking fundamental knowledge about the nature and behavior of living systems and
the application of that knowledge to enhance health, lengthen life, and reduce illness and disability.

Public health relevance
PROJECT NARRATIVE DNA damage, caused by environmental agents and the body’s normal processes, plays a critical role in the development of many major human diseases; in the U.S. alone, this potentially impacts one in two adults (~125 million people). While the comet assay is one of the most widely used and versatile methods for detecting cellular DNA damage, it is a time-consuming and labor intensive method. This proposal aims to develop a novel device for automating the comet assay, facilitating the simple and rapid measurement of DNA damage; advancing our knowledge of the role of DNA damage in health and disease, and hence promoting mitigation strategies and therapeutic interventions.